POLYUNSATURATED FATTY ACIDS SUPPLEMENTATION IN EXPERIMENTAL DIABETES

The purpose of the research is to establish the importance of manipulating the dietary fats in the prevention of diabetic nephropathy, using the streptozotocin-diabetic rat. Substitution of polyunsaturated for saturated fat and manipulation of the fatty acid metabolic pathways by drugs is being attempted.